Neural circuits for spatial navigation

Project Summary / Abstract
Our brain provides us with a sense of where we are in space. The importance of this sense is clear when we
become spatially disoriented, like when one is confused about one’s orientation after exiting a subway station.
Central to the understanding of how brains give rise to spatial cognition has been the discovery of place cells in
the 1970’s (i.e., neurons that are active when animals are in one specific location in space), head-direction
cells in the 1980’s (i.e., neurons that are active when animals face one specific compass direction), and grid
cells in the early 2000’s (i.e., neurons that are active when animals are in a grid of locations in space). A
remarkable feature of these cells is that their patterns of firing persist even when animals navigate in complete
darkness, wherein the animals must use an internal assessment of their own movements to update their sense
of position or orientation. A fundamental next step in our understanding of spatial cognition would be to
describe the circuit-level interactions that give rise to such physiological activity patterns and to understand
how such cells ultimately influence navigational behavior. Our recent work has uncovered the first neural circuit
to explain how heading-related cells update their activity levels when animals turn in the dark. This biological
circuit in Drosophila is a realization of a circuit proposed to exist in the mammalian brain twenty years ago,
based on computational modeling, but never proven to exist in any animal. Here we focus on three related
questions that aim to provide a deeper understanding of how brains construct navigational signals and how
these signals guide behavior. Our first aim is to identify a circuit path by which sensory information arrives to
the central brain to update the head-direction or heading system when an animal turns in the dark. Our second
aim is to determine the role of heading signals in guiding navigational behavior by perturbing the activity of
heading-related cells in animals performing a heading task. Our third aim is to characterize new cell classes
and circuitry to ultimately inform how brains might solve two-dimensional navigation tasks. The overarching
goal of this work is to provide a detailed, circuit-level understanding of how brains compute spatial navigation-
related variables. Such discoveries will inform our thinking on how our brains allow us to perform day-to-day
navigation tasks, like driving home from work or finding our car in a parking lot, and how to approach
psychiatric and neurological conditions in which these abilities are impaired, such as Alzheimer’s disease.

Public health relevance
Project Narrative Several dementias, including Alzheimer’s disease, include deteriorations in our ability to understand and remember where we are in space. A richer cellular and circuit-level understanding of how spatial navigation is achieved may inform novel therapeutic strategies for targeting these conditions, reducing the heavy burden they place on individuals and society.